HAZMAT Training at DOE Nuclear Weapons Complexes

The ICWUC Center for Worker Health and Safety Education (Center) seeks to continue the DOE
site-specific training to empower workers and communities to protect themselves during chemical
release and increase involvement in working cooperatively with leadership, contractors, and coworkers
in improving personal, community, and workplace emergency response. This training
raises the DOE site sufficiency and their surrounding communities by offering training from DOE
worker trainers at four sites, delivering 175 classes to 3,023 trainees during Year One.
Each site is fully operational and relies on local experienced worker trainers (Hanford, Oak Ridge,
and Kansas City). At the same time, Los Alamos National Laboratory (LANL) utilizes a blend of
Center staff and Kansas City trainers. IAMAW is a significant partner in these efforts,
representing members at two sites. The Center uses adult education principles and techniques
that rely on the knowledge and experiences of the participants to teach key principles in a nonthreatening
and engaging way that motivates trainees to improve their sites cooperatively with
leadership and their employing contractors to ensure each site’s safety and security. Classes to
be presented include a range of HAZWOPER-related classes, including a Superfund Site Worker
(12 classes; 248 trainees), 16-Hour Bridge classes for workers transferring into regulated areas,
and RCRA classes (11 classes, 180 trainees) with all covered workers taking refresher classes
annually (55 classes, 1,186 trainees). Fall protection and confined space programs will be
delivered to LANL and Hanford workers (87 classes; 1,911 trainees).
DOE worker-trainers from each site will deliver most training, a cost-effective resource to the
contractor and local union, and there will be 14 trainer development classes for 1,758 trainers
(many trainers advancing through mentorship and development programs.) This includes a DOE
trainers exchange, and we will continue our collaborative work with other Grantees. We will
continue our community outreach efforts, which have significantly expanded and should continue
to grow. We will continue to assess the workplace changes the program has produced through
the long- term evaluation of participants and trainers. As our past publication showed, these
trainers are invaluable resources for co-workers and managers who frequently answer requests
for their opinions on the appropriate practices, procedures, and equipment about health and
safety concerns (at least monthly). The trainers have also facilitated various workplace changes
through the joint efforts of trainers, participants, contractors, and site leadership.

Public health relevance
The ICWUC Center for Worker Health and Safety Education (Center) proposes a program to empower workers and nearby communities to tackle chemical emergencies. Trained worker teams from four DOE sites will share their expertise, foster collaboration and improve emergency response plans for everyone involved. To ensure program success, DOE site leadership and Center trainers will leverage the Center's expertise to identify specific training courses, accurately determine employee needs, and ensure the training aligns with site requirements, training gaps, and established safety protocols.